PREDICTION ERROR MEASURES FOR CONTINUOUS TIME COMPETING RISK MODEL

PREDICTION ERROR MEASURES FOR CONTINUOUS TIME COMPETING RISK MODEL IN TWO-TIME SCALES. THIS CONTRACT SHALL EXTEND METHODS FOR RISK PREDICTION WITH A CONTINUOUS TIME MODEL